Diversifying Acute Leukemia Clinical Trial Enrollment Through Multilevel Intervention

PROJECT SUMMARY/ABSTRACT
Race-ethnic disparities in cancer clinical trial enrollment bias research findings, limit generalizability, and
reduce equitable access to the novel therapies and high-quality care that trials provide. Acute myeloid and
lymphoblastic leukemia are aggressive but curable blood cancers that affect 170,000 persons nationally, and
incidence-adjusted trial enrollment of Black and Hispanic adults with these cancers is among the lowest
known—up to 85% less than White patients. These leukemias have a distinct care pattern that limits the utility
of existing, community-based enrollment diversity interventions: patients require rapid inpatient therapy and up
to half are seen at quaternary referral centers, where a significant proportion of disparate enrollment occurs.
Modifiable elements of trial design, low provider empowerment, and patient hesitancy behaviors appear to play
key roles in perpetuating this disparity. Recent policy and data science innovations now allow cancer registry
and electronic health record data integration for enrollment diversity monitoring and intervention development.
The goal of this proposal is to leverage these advances, developing three complementary projects that
together comprise a multilevel intervention for overcoming barriers to diverse enrollment in acute leukemia. In
Aim 1, a preemptive trial protocol review system will be developed to identify acute leukemia trial design
elements associated with enrollment disparities using a predictive risk score and community assessment. In
Aim 2, an enrollment diversity performance feedback interface for acute leukemia providers will be constructed
within the medical record and piloted. In Aim 3, an enrollment peer support mobile application will be
developed and piloted for patients with acute leukemia. Completion of these projects will result in a fully
developed multilevel intervention that has the potential to sustainably diversify acute leukemia trial enrollment
at scale, which will be tested through a large, randomized trial. This work will simultaneously generate
replicable methods for monitoring enrollment diversity and disparities intervention assessment across
institutions and cancer types. This research will be complemented by training that will cultivate expertise in
behavioral intervention development, community-based participatory research, and multilevel health disparity
interventions through formal coursework, workshops, seminars, and a strong team of mentors and
collaborators. The work will take place within a leading cancer center that has a track record of care delivery
innovation and early-career investigator success. Together, this research proposal and training plan target the
primary investigator’s near-term objective of becoming an independent investigator characterizing blood cancer
care delivery inequities and developing interventions to improve access, quality, and outcomes for
marginalized groups. By creating a multilevel intervention that has the potential to improve the safety, efficacy,
quality, generalizability, and community engagement of clinical research for diverse participants, this proposal
also aligns with primary investigator’s long-term career goal of ensuring equity in blood cancer care delivery.

Public health relevance
PROJECT NARRATIVE Race-ethnic disparities in acute leukemia clinical trial enrollment limit the generalizability of study findings and equitable access to high-quality care, while acute leukemia’s unique care patterns limit the utility of existing interventions to reduce them. I propose to combine community engagement with data science methods to develop a multilevel intervention targeting key trial enrollment barriers through three complementary pilot studies: a review system to preemptively modify trial design elements associated with enrollment disparities, an enrollment diversity performance feedback interface for physicians, and a peer-based support application for patients. Together, these interventions promise to create low-cost and scalable methods for diversifying cancer clinical trial enrollment as I prepare for an independent research career focused on ensuring equity in cancer care delivery.